Clinical and Translational Science Center

Contact PD/PI: IMPERATO-MCGINLEY, JULIANNE L
OVERALL
PROJECT SUMMARY/SUMMARY
The Weill Cornell Medicine Clinical and Translational Science Center’s (CTSC) future strategies are built on the
considerable accomplishments achieved over the last 14 years, providing the translation of research and the
generation of research ideas that pave the way for future innovations despite the effect of the pandemic on the
medical school, with the city in lockdown for over 14 months. The plans for the next five years are devised to
continue to develop the existing infrastructure and its initiatives, to add new ones, to enhance networking, and
to improve diversity, equity, and inclusion. In so doing, we will continue to advance translational science to
improve community health. With our multi-institutional hub of distinguished partners firmly in place, the strategic
plans for the CTSC are geared to rapidly advance translational science discovery by: 1) Enhancing informatics
to increase resource adoption, reduce roadblocks and streamline workflow through training, novel software, and
new collaborations; 2) Improving health inequities, developing strong translational research engagement with
communites, and preparing for health crises, like the COVID-19 pandemic, where the CTSC organized a
vaccination hesitancy program and set up vaccination sites in underserved communities; 3) Continuing to
develop our highly successful clinical and translational education programs through innovative and
entrepreneurial multifaceted initiatives including training in health disparities and a new cross-hub KL2/TL1
collaboration with the Georgetown/Howard CTSA; and 4) Creating Team Science initiatives that promote
inclusion across the CTSC. Innovative didactic opportunities will continue to be offered and expanded, such as
seminars on innovation and entrepreneurship, the newest of which will be a collaborate with eLab on “Unmet
Needs for Stimulating Device Development,” a five-part series which is designed to stimulate device
development. The Pilot Translational and Clinical Studies program will be enhanced to target projects in device
and therapeutics development, precision medicine and research in special populations while promoting
collaborations between the community, community organizations and CTSC Investigators. The CTSC also offers
educative opportunities that reach the broader community such as our Teaching Ethics Through Art program,
while the Special Population Network (SPN) will expand to include community outreach studies and continue
clinical research studies with a focus on the following populations: children, the elderly, ethnic and racial
minorities and those with disabilities. Additionally, the Network Capacity Component will do more outreach to
encourage local investigators to initiate multi-center clinical trials. The CTSC has also been extremely successful
ensuring the availability of biostatisticians from all partners with expertise in diverse disease systems and with
adequate computational resources to support the design and conduct of research studies performed within the
CTSC. All of these initiatives allow the CTSC to accomplish its goal of translating science to improve public
health more effectively and efficiently.
Project Summary/Abstract Page 298
Contact PD/PI: IMPERATO-MCGINLEY, JULIANNE L

Public health relevance
Project Narrative The ultimate goal of the multi-institutional Weill Cornell Clinical and Translational Science Center (CTSC) is to transform the national translational research enterprise to improve human health by supporting high quality clinical and translational research and research training. In the upcoming funding period, the CTSC will, with its partners at Memorial Sloan Kettering Cancer Center, Hospital for Special Surgery, Hunter College, School of Nursing, School of Urban Public Health; of City University of New York), Cornell University at Ithaca and the Animal Medical Center will continue to develop the existing infrastructure and its initiatives, to add new ones, to enhance networking, and to improve diversity, equity, and inclusion. In so doing, we will continue to advance translational science to improve community health, enhancing informatics to improving health inequities, and preparing for health crises, like the COVID-19 pandemic. continuing to develop our highly successful clinical and translational education programs, creating Team Science initiatives that promote inclusion across the CTSC. Project Narrative Page 299